Initiating Preventive Care for Hyperlipidemia in the Emergency Department: The EMERALD Trial

PROJECT SUMMARY/ABSTRACT
Hyperlipidemia (HLD) is a major contributor to atherosclerotic cardiovascular disease (ASCVD), the leading
cause of US mortality and morbidity. Nearly 30% of Emergency Department (ED) patients with chest pain have
undiagnosed and/or unmanaged HLD, putting them at an increased risk of ASCVD. Although safe and
effective HLD treatments exist, the ED traditionally focuses on acute care and does not offer preventive
cardiovascular care services or treatment for HLD. This represents a large, missed opportunity to improve
cardiovascular health for the millions of Americans evaluated in the ED each year for chest pain who are not
receiving appropriate guideline-directed preventive care in the outpatient setting. The overarching research
goals of this study are to determine the efficacy of a novel, protocolized, ED-based preventive care
intervention for HLD known as EMERALD (Emergency Medicine Cardiovascular Risk Assessment for Lipid
Disorders) in lowering cholesterol while also informing our understanding of patient adherence and
implementation determinants of ED-based preventive cardiovascular care. To accomplish these goals, I
worked with my mentoring team to design a career development plan that blends multidisciplinary research
training with an innovative research proposal. Aim 1 will use a randomized, controlled, single center, parallel
group trial of 130 ED patients to test the efficacy of EMERALD vs. usual care in lowering cholesterol. Aim 2 will
rely on mixed methods to identify patient adherence facilitators and barriers as well as implementation
determinants for Emergency Medicine providers. To successfully accomplish these Specific Aims, I will
capitalize on the outstanding research environment at the Wake Forest University School of Medicine and my
engaged transdisciplinary mentorship team of senior scientists. With support from my mentoring team, I will
complete a robust career development program that will provide me with the necessary training in preventive
cardiovascular care, clinical trial design and methodology, and qualitative methods that are needed for me to
become an independent investigator and national leader with expertise in ED-based preventive cardiovascular
care strategies. The proposed K23 Award aligns with NHLBI's objective to “Develop and optimize novel
diagnostic and therapeutic strategies to prevent, treat, and cure heart, lung, blood, and sleep diseases,” with
position statements from Emergency Medicine and Cardiology professional societies, and with the Department
of Health and Human Services “Healthy People 2030” initiative. This proposal will inform our understanding of
ED-based preventive cardiovascular care strategies and will help me achieve my long-term goal of becoming
an independent investigator focused on ED-based preventive cardiovascular care.

Public health relevance
PROJECT NARRATIVE Nearly 30% of Emergency Department patients with chest pain have undiagnosed and/or unmanaged high cholesterol, which represents an opportunity for Emergency Medicine providers to improve health for the 8-10 million patients who receive care in an Emergency Department each year for chest pain. This study will address a critical gap in knowledge by determining the efficacy of an Emergency Department-driven cardiovascular disease prevention program that aims to identify and treat patients with high cholesterol. This is a highly significant and innovative study as it evaluates the first Emergency Department-based preventive cardiovascular care approach for high cholesterol, which could also be applicable to other cardiovascular disease risk factors among Emergency Department patients.